A digital intervention to improve skin self-examination among melanoma survivors

ABSTRACT
With incidence rates more than tripling in the last 45 years, the population of melanoma survivors in the US is
estimated at more than a million persons. Survivors are at elevated risk for recurrence and new primary
cancers. Most recurrent melanomas are found by survivors themselves, which is why physicians educate
survivors about the importance of regular, thorough skin self-exams (SSE) and why professional guidelines for
follow-up surveillance recommend regular, thorough (SSE). More than two thirds of melanoma survivors do not
perform regular, thorough SSE. To address this significant problem, our experienced team developed a digital
intervention, called mySmartSkin (MSS), and tested it in an RCT against usual care in New Jersey. MSS
illustrated promising effects on thorough SSE. In this application, we propose to prepare MSS for large-scale
dissemination using an innovative Type 1 hybrid effectiveness-implementation trial. A Type 1 hybrid
effectiveness-implementation design allows us to engage multilevel stakeholders throughout the research
process, evaluate the effectiveness of the enhanced MSS, and identify critical factors for wide-scale
implementation. The study’s three aims are guided by implementation frameworks and behavior change
theories. In Aim 1, we will enhance MSS using multi-level stakeholder engagement by collaborating with key
stakeholders in enhancing MSS through qualitative interviews and usability testing of potential enhancements.
Potential enhancements are based on empirically-validated behavior change techniques (BCTs) and findings
from our prior study. We will utilize an iterative process that includes key informant interviews with survivors,
providers, and relevant professional organizations regarding proposed enhancements, conversion to an
enhanced mobile-based intervention delivery platform, usability testing with survivors, and iterative program
refinements. Aim 2 compares the effects of enhanced MSS vs. a non-interactive educational webpage on
comprehensive SSE in an RCT with survivors recruited through two state cancer registries and social media
(N=300). In Aim 3, we identify factors relevant to future scale-up for widespread dissemination and
implementation using mixed methods to assess selected implementation outcomes from the RCT and explore
perspectives from survivors, care providers, and professional organizations about how to best disseminate and
implement MSS on a broad scale. We will estimate program costs and assess cost-effectiveness of MSS. This
project addresses a documented gap in care for melanoma survivors by enhancing effects of a promising
survivor-facing intervention and proactively identifying barriers and facilitators to future implementation. We
innovatively “design for dissemination” by ensuring that enhancements are designed with the target population
of potential users. Serving as a model for optimizing promising fully-automated online interventions for cancer
survivors for dissemination, this project will provide important information about potentially cost-effective ways to
reach survivors as well as about how to adapt such an intervention for dissemination.

Public health relevance
PROJECT NARRATIVE Survivors of invasive cutaneous melanoma are at high risk for skin cancer recurrence and new primary cancers, and regular thorough skin self-examination (SSE) is recommended to reduce these risks. The proposed study seeks to enhance the promising initial effects of MySmartSkin, a fully automated online intervention developed by our team, on performance of thorough SSE and prepare MySmartSkin for widespread dissemination and implementation among melanoma survivors. This work will advance the science of cancer survivorship by optimizing a promising surveillance and prevention-focused intervention for an underserved group of cancer survivors and preparing for widespread dissemination and implementation.